Chemoenzymatic construction of synthetic human milk oligosaccharide (HMO) glycome

Project Summary
Chemoenzymatic construction of synthetic human milk oligosaccharide (HMO) glycome
Human milk oligosaccharides (HMOs) constitute a major component of human milk which provides everything
that breast-fed infants need in the first several months of their lives. There is an increasing appreciation of the
multifaceted contribution of HMOs to the health of breast-fed infants. Exploring the applications of HMOs as
infant formula additives, nutraceuticals, and/or therapeutics has begun but has been slow due to the limited
access to structurally defined HMOs in sufficient amounts. The structures of more than 150 HMOs are known.
Despite efforts and advances in developing chemical, enzymatic, chemoenzymatic, and fermentation methods
for HMO synthesis, the access to a complete HMO glycome has not been achieved synthetically. HMOs can be
purified from human milk but the amount is limited. We plan to lower the technical barrier to access HMOs by
developing highly efficient user-friendly glycosyltransferase-based chemoenzymatic methods and construct a
comprehensive synthetic HMO glycome. Other than the enzymes, the chemoenzymatic synthetic strategies, and
the production processes that have been developed, additional innovation will be introduced for substrate and
process engineering. New enzymes will be identified, engineered, characterized, and used for the synthesis of
HMOs in a systematic target-oriented manner. Maps for chemoenzymatic synthetic routes will be developed. A
comprehensive library of HMOs including branched and long-chain linear structures with or without L-fucose
and/or sialic acid that have been identified from human milk and potential isomers that have not been identified
will be constructed. The synthetic HMO glycome will provide well characterized pure compound standards for
identifying and profiling of HMOs in the milk from different nursing mothers, at different lactation stages, and with
or without infections or other diseases. The chemoenzymatic synthetic process is programmable, can be adapted
for automation, and is readily scalable for large-scale production of HMOs in the future.

Public health relevance
Project Narrative Chemoenzymatic construction of synthetic human milk oligosaccharide (HMO) glycome Efficient and innovative methods will be developed and related enzymes will be identified for target-oriented chemoenzymatic synthesis of human milk oligosaccharides (HMOs) in a systematic manner. The resulting compounds are important standards for analysis, probes to identify HMO-binding proteins, and reagents to explore the multifaceted applications of HMOs as infant formula additives, potential nutraceuticals and therapeutics. The chemoenzymatic synthetic process is programmable, can be adapted for automation, and readily scalable for large-scale production of HMOs in the future.